CORE--Coordination

The coordination Core will subserve all three projects of the Program for several key functions. These include: monitoring of budgets, management of regulatory affairs, data management, coordination of clinical studies and biostatistical support. In addition, an External Scientific Advisory Committee functions through this core to provide review and recommendations to the senior leaders of the program. The core will e directed by Dr. Chang. All of the individuals in this core are highly experienced in their assigned tasks.